Development and Commercialization of a pupillometer to predict postoperative opioid-induced respiratory depression in children

PROJECT SUMMARY
With about 50 million surgeries performed annually in the US. Opioids are commonly used as primary analgesics
to control severe surgical pain. However, opioids are associated with several adverse effects including nausea,
vomiting, sedation, and more serious respiratory depression and death. Respiratory depression is recognized
as one of the most serious, life threatening and costly complications from perioperative opioids. Although
preventable in patients undergoing surgery with effective and early predictions, opioid-induced respiratory
depression continues to be a major contributor to increased morbidity, mortality, length of hospital stay, cost of
healthcare and malpractice claims. The cost associated with postoperative opioid-induced respiratory
depression in the US is over $650 million annually and $231 million for children alone. While adults with
respiratory and cardiovascular concerns are at high risk of respiratory depression, children are particularly
vulnerable. Over 60% of children undergoing tonsillectomy – the most common surgical procedure in children –
are likely to experience adverse post-operative effects including respiratory depression. Current approaches rely
on reactive and delayed identification of respiratory depression using costly monitoring and extended hospital
stay for patients. Currently, there is no effective tool to proactively and reliably identify patients at high risk of
opioid-induced postoperative respiratory depression. To address this urgent and unmet need, NeurOptics is
developing a first-in-class pupillometry-based tool to proactively predict postoperative respiratory depression in
children. This technology is based on the patented pupillometry-based respiratory depression prediction model
developed by Dr. Sadhasivam through his NIH-funded clinical research. NeurOptics and Dr. Sadhasivam aim to
bring this technology to wide clinical use through this accelerated SBIR Fast-Track proposal. In Phase I,
NeurOptics will complete the development of a fully functional prototype, the A-100 device and Intelligent Patient
Interface (IPI), as proof-of-concept. Additionally, during this phase, NeurOptics will engage with the FDA for
feedback on the regulatory pathway including the first-of-kind, breakthrough device designation for the A-100.
In Phase II, NeurOptics will manufacture beta units of the device and patient interface. These will be verified and
used to validate the proposed technology through a clinical study with children undergoing tonsillectomy
conducted in collaboration with Dr. Sadhasivam. The perioperative use of this technology will help clinicians to
prevent respiratory depression, improve safety of opioids while allowing hospitals to optimize resources. Based
on the current opioid-epidemic related public health crisis and socio-economic burden of opioids (>$500
billion/year), a significant commercial market exists for NeurOptics to proactively identify and effectively reduce
opioid-related adverse effects including respiratory depression and overdoses in millions of Americans each
year.

Public health relevance
PROJECT NARRATIVE Opioid-induced respiratory depression is a life-threatening concern that is preventable in patients undergoing surgery yet continues to be a major contributor to costly morbidity, mortality, length of hospital stay, and malpractice claims. NeurOptics is developing a pupillometry-based easy to use, bedside tool to predict postoperative respiratory depression in children in real-time. The perioperative use of this innovative and impactful technology will help clinicians to prevent respiratory depression, improve safety surgical pain management with opioids while reducing perioperative cost of care with optimal hospital resource utilization.